Developing programmable RNA writing tools with the novel RNA-guided RNA-targeting CRISPR effector Cas7-11

Project Summary: While gene editing technologies have revolutionized the ability to programmably edit DNA
with high efficiency in diverse tissues, there remain several challenges with DNA editing, including permanent
off-targets, concern for permanent correction of certain diseases, and some diseases being better targeted by
other modalities than gene editing. For example, treatment of triplet repeat disorders with gene editing remains
difficult, due to the difficulty of targeting repeat regions in the genome and the need to make large and precise
deletions, without causing off-target genome rearrangements and other undesired effects on the genome. RNA
modifications, however, may offer a better approach with notable features: 1) temporal and reversible
modification of genetic diseases, 2) minimal off-targets which are reversible and less harmful, and 3) more
versatile editing beyond genome editing. For example, with triplet repeat disorders, an RNA writing strategy
could allow for collapse of the repeats to the exact desired number, an approach that would be more
successful than gene editing or RNA knockdown strategies that have failed. To accomplish RNA writing, which
involves all possible base edits (transitions and transversions), small or large insertions, and small or large
replacements (e.g. exon swapping), some approaches have been developed, such as trans-splicing, but with
limited success. Trans-splicing relies on the recruitment of an RNA template to a pre-mRNA without any active
targeting domains and involves competition with the cis target. As a result, programmable trans-splicing has
had low efficiency. We hypothesized that combining trans-splicing with programmable RNA guided CRISPR
systems could help boost the efficiency of the trans-splicing mechanism, enabling any potential type of RNA
edit, insertion, deletion, or replacement to be incorporated into endogenous transcripts. While we and others
have characterized novel programmable RNA targeting CRISPR systems, such as Cas13, and developed tools
from these systems, use of these tools have been limited in cellular systems due to a non-promiscuous
cleavage activity known as collateral activity. While Cas13 has been shown to have specific RNA cleavage
activity in some cell types, other cell types have had significant collateral cleavage of cellular RNAs, leading to
toxicity in cell models. The proposed work will address these needs by combining biochemical characterization,
structural characterization, and enzyme engineering to develop new RNA targeting CRISPR nucleases
without collateral activity, such as the novel CRISPR-Cas7-11 enzyme, for specific RNA writing tools in
conjunction with trans-splicing to enable any possible RNA edit. Beyond optimizing the RNA writing technology
via trans-splicing optimization using RNA and protein engineering, we will showcase RNA writing’s therapeutic
potential by correcting triplet repeat disorders in iPSC-derived human neurons. The developed technologies in
this proposal will accelerate the pace of biomedical research and enable treatment of many genetic disorders,
many of which are not treatable with gene editing, bringing more therapies to patients.

Public health relevance
Project Narrative Programmable nucleic acid targeting tools such as CRISPR provide a new modality for programmable RNA targeting but current RNA-targeting tools suffer from potential issues with safety, specificity, and versatility. We propose to develop new, specific RNA-targeting CRISPR systems without off-target collateral activity in cells and engineer these systems to generate new RNA writing technologies capable of all possible base conversions, insertions or deletions of any size, and exon replacement. The technologies developed from this work will accelerate the study and modeling of disease biology and provide a revolutionary platform for RNA-based therapeutics, including many triplet repeat disorders.